Mechanisms of Noninvasive Ultrasonic Neuromodulation of Parkinsonian Neural Circuits

PROJECT SUMMARY/ABSTRACT:
Parkinson's disease (PD) is characterized by the progressive degeneration of dopaminergic neurons in the
substantia nigra pars compacta, leading to debilitating motor symptoms such as bradykinesia, rigidity, and
tremor. Current treatments, such as dopamine replacement therapy and deep brain stimulation, provide
symptomatic relief but do not halt disease progression or offer sustained efficacy. Consequently, there is a shift
toward non-invasive neuromodulation techniques such as low-intensity focused transcranial ultrasound (TUS).
Recent clinical studies, including those by Co-Sponsor Dr. Robert Chen, have shown that theta burst TUS can
improve motor symptoms in PD patients by increasing motor cortex excitability and reducing bradykinesia.
However, the precise mechanisms by which TUS modulates neural activity and cellular dynamics remain
unclear. Our recent research using cellular calcium imaging demonstrated that TUS at specific pulse repetition
frequencies (PRFs) can selectively activate neuron populations in the motor cortex of awake mice, indicating
that TUS can precisely influence neural circuits. The goal of this proposal is to investigate how TUS
modulates neuronal activity with subcellular spatial resolution and millisecond temporal resolution in
the awake mammalian brain. First, we will examine how different TUS PRFs modulate the membrane voltage
of individual neurons in the motor cortex and striatum of awake mice using kilohertz voltage imaging. We
hypothesize that TUS will effectively entrain neuronal oscillations and modulate membrane voltage, providing
the first direct experimental evidence on how TUS modulates individual neurons in the awake mammalian brain.
Our preliminary results show that TUS can entrain individual neuron membrane voltage in the motor cortex at
10 Hz and 40 Hz (Aim 1). Secondly, I will directly measure the effect of theta burst (5 Hz PRF, used clinically by
Dr. Chen) and beta burst (10 Hz in mice) TUS on dopamine terminals in the striatum and its downstream targets,
the striatal cholinergic interneurons using simultaneous calcium and voltage imaging. By targeting TUS to the
cortico-basal ganglia-thalamic loop, we aim to demonstrate how TUS influences dopaminergic transmission and
neuronal dynamics, hypothesizing that TUS leads to simultaneous activation of pre-synaptic dopamine terminals
and post-synaptic cholinergic interneurons (Aim 2). Such results will provide direct experimental evidence on the
pre- and post-synaptic effect of TUS, providing important insights on the fundamental principles underlying TUS
neuromodulation. Finally, we will explore the effects of TUS on behavior and neuronal activity in a PD mouse
model. Using a dopamine depletion PD model, we will assess TUS-evoked changes in dopamine terminals,
cholinergic interneuron membrane voltage, locomotion, and dopamine neuron survival. We anticipate that TUS
at theta frequencies will improve motor function and enhance dopamine neuron survival (Aim 3). This research
will provide critical insights into the mechanisms of TUS neuromodulation, paving the way for its clinical
application in PD treatment.

Public health relevance
PROJECT NARRATIVE: Recent progress in transcranial ultrasound (TUS) has brought increasing excitement to the potential of developing a new generation of non-invasive neuromodulation for Parkinson's disease (PD). The goal of this research proposal is to understand how TUS modulates neuronal dynamics using in-vivo cellular imaging with single-cell, single-spike level precision in the motor cortex and striatum of awake, behaving mice, as well as characterizing its impact on dopaminergic transmission and motor function. This work could provide invaluable insight into how PD neural circuits respond to TUS in both pathological and nonpathological states, offering a mechanistic understanding for therapeutic intervention.